Minnesota Nathan Shock Center of Excellence on Genome Integrity and Aging

There is strong evidence that changes in the primary aging hallmark of genomic instability, especially the
accumulation of DNA damage and the resulting DNA damage response (DDR) signaling cascade, leads to
changes in other hallmarks of aging, including cellular senescence, inflammation, epigenome, proteostasis,
dysbiosis, and mitochondrial and stem cell dysfunction. Thus, there is a clear need to be able to quantitate and
characterize the extent of DNA damage and DDR signaling comprising a key primary hallmark of aging and to
quantitate DNA repair activity. The goal of this Minnesota (MN) Nathan Shock Center of Excellence on
Genome Integrity and Aging (MN NSC) is to provide access to cores with the ability to accurately measure
specific endogenous DNA adducts reflecting oxidative and metabolic stress in genomic DNA, the signaling
associated with the DDR, including markers of senescence, and the extent of DNA repair activity as well as
measure certain DNA methylation epigenetic changes associated with DNA damage and age. Also, the MN NSC
will provide access to murine and human cells and tissues and mice with reduced DNA repair capacity and
increased DNA damage, senescence and other hallmarks of aging. In addition, the MN NSC will provide access
to mouse models with accelerated DNA damage for testing of agents for their ability to reduce DNA damage
and/or the effects of DDR on other aging hallmarks. To accomplish this, the MN NSC will leverage existing
resources and strong institutional support within the new UMN Institute on the Biology of Aging and Metabolism
(iBAM) as well as the University of Minnesota (UMN). The MN NSC and the Administrative and Program
Enrichment Core (A/PEC) A are co-directed by Drs. Paul Robbins and Laura Niedernhofer, Co-Directors of
iBAM, both recognized experts in DNA damage, senescence, inflammation and aging and with a strong track
record in mentoring young investigators. The Research Development Core B (RCD) is co-directed by Drs. Paul
Robbins (UMN) and Doug Mashek, who directs a UMN graduate program and is working on the novel role of
lipid droplets in regulating DNA repair and senescence. The DNA Damage and Epigenetic Changes Core C is
co-directed by Drs. Natalia Tretyakova and Peter Villalta, providing quantitative and reproducible mass
spectroscopy approaches for accurately measuring oxidative DNA lesions and methods for measuring DNA
methylation changes that occur following DNA damage. The DNA Damage Signaling and Repair Core D is co-
directed by Drs. Revelo and Elizabeth Schmidt, providing CyTOF single cell analysis of DNA damage, DDR
signaling and senescence at the protein level in single cells and measuring DNA repair capacity in primary cells.
Finally, the Models of Genome Instability and Aging Core E, directed by Drs. Laura Niedernhofer and
Christina Camell, will provide mouse and human cells and tissues deficient in different key DNA repair proteins
as well as access to mouse models of accelerated DNA damage, senescence and aging for drug testing.

Public health relevance
PROJECT NARRATIVE - MN NSC ON GENOME INTEGRITY AND AGING Robbins & Niedernhofer The goal of this Minnesota (MN) Nathan Shock Center of Excellence on Genome Integrity and Aging (MN NSC) is to provide access to innovative cores with the ability to accurately measure genome instability, a primary hallmark of aging, and provide mentoring to junior faculty and trainees. Specifically, the MN NSC Cores will provide access to methods to measure specific types of oxidative DNA damage, the most prevalent type of damage with age, the signaling associated with the DNA damage and the extent of DNA repair activity and measure certain epigenetic changes associated with DNA damage as well as measure senescence markers. Also, it will provide access to murine and human cells and tissues and mice with reduced DNA repair capacity and increased DNA damage and senescence.